Excess cardiovascular inflammation in TB and HIV: EXFIN-TB

TB is the leading global killer among infectious diseases and the number one cause of death among those
with HIV. Furthermore, the estimated 9 million TB survivors completing treatment each year have a 3-fold
increased risk of death from any cause when compared to those without previous TB. While post-TB lung disease
is a major contributor to the long-term morbidity and mortality faced by TB survivors with and without HIV
coinfection, cardiovascular disease accounts for a greater proportion of post-TB deaths than pulmonary disease.
Moreover, epidemiologic studies have found that adults with a history of previous TB have a ~50% increased
risk of cardiovascular events. Importantly, many endpoints in existing studies occur years after TB treatment
completion, raising the possibility that TB promotes subclinical vascular dysfunction, which then predisposes
survivors to future cardiovascular disease events. If true, it may be possible to identify high-risk patients and
intervene early—during or soon after TB treatment—before these events occur.
Our overarching hypothesis is that TB promotes pulmonary inflammation that leads to subclinical vascular
pathology characterized by increased arterial stiffness, vascular intima-media thickening, and endothelial
dysfunction, all of which drive an increased risk of major cardiovascular events. Further, we hypothesize that
patients with more severe pulmonary involvement, as determined by baseline chest high-resolution computed
tomography (HRCT) scan, will display worse vascular pathology after TB treatment completion. Support for this
hypothesis comes from studies linking more severe viral and bacterial respiratory infections with a greater risk
of future cardiovascular events. In addition, we will investigate the role of inflammasomes, which are molecular
complexes of the innate immune system that are activated by TB and known to be causally involved in the
development of atherosclerosis, ischemic heart disease, and stroke.
For this “Excess Cardiovascular Inflammation in TB and HIV: EXFIN-TB” study, we will leverage our ongoing
prospective cohort study of post-TB lung disease in patients with and without HIV coinfection. In Aim 1, we
hypothesize that TB patients with greater initial involvement on HRCT will have more arterial stiffness 36 months
after TB diagnosis. In Aim 2, we hypothesize that higher sputum levels of the inflammasome cytokine IL-1β
during the first month of TB treatment will have more arterial stiffness 36 months after TB diagnosis. Given the
importance of HIV to the TB epidemic, both aims will be evaluated in parallel cohorts with equal numbers of
people with and without HIV (n = 125/group). We will also newly enroll 120 community controls without TB
disease, with whom all outcomes will be compared. Secondary analyses will incorporate additional measures of
TB severity, functional assays of inflammasome activity, and complementary measures of vascular pathology.
Knowledge gained from this study will directly inform future mechanistic and therapeutic studies with the goal of
reducing the burden of post-TB cardiovascular disease for millions of TB survivors.

Public health relevance
PROJECT NARRATIVE A growing body of literature indicates that people successfully treated for TB disease have an increased risk of all-cause mortality, with cardiovascular disease being the leading cause of post-TB deaths. However, risk factors for post-TB cardiovascular disease are unknown and there are no interventions targeted towards reducing this risk. By characterizing clinical risk factors and inflammatory pathways associated with subclinical cardiovascular disease in people treated for TB, this study will inform future treatment strategies to prevent or reduce long-term cardiovascular morbidity and mortality among TB survivors.